TITLE: "DETERMINATION OF 5-FLUORO-2'-DEOXYCYTIDINE (FDCYD), SELECTED DOWNSTREAM METABOLITES (FDURD, FU), AND TETRAHYDROURIDINE (THU) LEVELS IN HUMAN.." PERIOD OF PERFORMANCE 5/1/2018 - 8/31/2021

Stepping stones project for testing formulations for small molecule drug candidates for early PK assessments.